Personalized Risk Prediction for Prevention and Early Detection of Postoperative Failure to Rescue

Abstract
In the Hospital of the Future hospitalization will be reserved almost exclusively for patients with severe acute
illness, staff numbers will be reduced, and hospitals will be built around smart environments that facilitate
consistent delivery of effective, equitable, and error-free care focused on patient-centered rather than provider-
centered outcomes. This is particularly relevant to the surgical population. While ambulatory surgical centers
are the fastest growing providers, more than 51 million inpatients procedures are performed annually in
hospitals in the US and inpatient surgery centers are taking care of sicker and older patients. While
intraoperative mortality is rare due to improvements in surgical techniques, anesthesia management, and
intraoperative monitoring, global postoperative mortality remains the third leading cause of death among
American People. Recent studies have shown that while the incidence of postoperative major complications
after major surgery is similar between hospitals (~25%), the postoperative mortality following postoperative
major complications from one hospital to the other can be up to 2.5-fold higher. This suggests that reducing
variations in mortality following major surgery will require strategies to improve the ability of high-mortality
hospitals to manage postoperative major complications and decrease failure-to-rescue. One of the solutions
identified is to leverage Health Information Technologies. The goal of this proposal is to use machine learning
approaches to develop, validate, and test real-time postoperative risk prediction tools based on multi-modal
data sources using electronic health record data, high-fidelity physiological waveform features, and genomic
data to identify patients who are at risk of developing postoperative major complications after surgery. Using
extensive electronic health record derived annotation augmented with high-fidelity physiological waveform
features and genomic data and applying state-of-the-art machine learning approaches, common patterns in
subjects destined to develop postoperative major complications and those at very low risk of developing
postoperative major complications after surgery will be characterized and quantified. These inputs will then be
used in simulated real-time bedside management to iteratively design a prototype clinical decision support tool.
This clinical decision support tool will be used at discharge from the post anesthesia care unit to identify
surgical patients who will benefit from continuous remote monitoring and early warning system on the ward to
prevent postoperative failure to rescue. The feasibility and acceptability of this approach will then be assessed
in a small-scale prospective, longitudinal pilot evaluation in sequential 10-weeks, 13-weeks, 10-weeks phases
at UCLA to help design a future, large-scale clinical trial.

Public health relevance
Project Narrative The goal of this proposal is to apply machine learning approaches to multiple data sources including electronic health record data, high-fidelity physiological waveform data, and genomic data that have never been used together in the acute care setting to predict postoperative major complications and decrease failure-to-rescue after surgery. These inputs will be used in simulated real-time bedside management to 1) iteratively design a prototype clinical decision support tool and 2) evaluate its use in simulation upon use of postoperative continuous remote monitoring and early warning systems, accuracy and time to correct diagnosis, accuracy of intervention, and time-to-intervention. The feasibility and acceptability of this clinical decision support tool will then be assessed in a small-scale prospective, longitudinal pilot evaluation in sequential 10-weeks, 13-weeks, 10-weeks phases to help design a future, large-scale clinical trial.